Cancer Research Training and Education Coordination

PROJECT SUMMARY/ABSTRACT
Training and education have a long-standing legacy at the Sidney Kimmel Comprehensive Cancer Center
(SKCCC). The goal of this Cancer Research Training and Education Coordination (CRTEC) program is to
coordinate and track the success of these activities while working with Program Leaders and SKCCC's
leadership to identify new areas of need that will align with SKCCC's strategic plan. CRTEC's priority is to train
a well-equipped and diverse workforce that meets future challenges in cancer research. Programs span career
stages from high school students to junior faculty. Training is cross-disciplinary and includes dedicated
programs for oncology nursing, pharmacy, genetic counselors, as well as science educators in the catchment
area. CRTEC's portfolio includes seven NCI-funded T32 training grants; six additional T32 training grants are
led by SKCCC members and have a significant cancer focus. These programs support pre- and post-graduate
trainees in cancer epidemiology, nanotechnology, molecular medicine, and immunology among others. Several
are dedicated to training physician-scientists including medical, pediatric, and surgical oncologists. Cancer
relevant peer reviewed funding is $10.1M with $5.1M from the NCI. CRTEC benefits from strong institutional
support with a $2.8M annual budget that supplements training grants, facilitates CME activities, and supports
new training programs. Since Dr. Mary Armanios was recruited as Associate Director for CRTEC in 2019, she
founded and leads the Office of CRTEC. Dr. Armanios has refined governance to include new working
committees with oversight from a Steering Committee. An Internal Advisory Board provides bi-directional
feedback with Johns Hopkins University (JHU) entities. CRTEC coordinates widely attended courses, retreats,
and CME activities. A new NCI-funded R25 program disseminates a curriculum on cancer pain management
nationally. Workshops addressing anti-racism and cutting-edge technologies have been introduced and
CRTEC serves as a single point of contact for making these opportunities available to JHU faculty, staff and
trainees. CRTEC has leveraged existing JHU programs to create new oncology threads for undergraduate and
post-baccalaureate students; these have 40-70% matriculation rates into graduate and medical school. A
research program for medical students from underprivileged universities has 37% minority representation and
27% of students have entered oncology careers. A new grant writing curriculum supports trainees and junior
faculty through workshops, internal review, and a Grant Club; these efforts have led to 50%-80% funding rates
in the first two years. CRTEC implements programs to support women and minorities including recently to
mitigate the pandemic's effects on workforce diversity. During the next period, CRTEC will use existing
resources to more comprehensive track trainee and junior faculty outcomes through a newly created metrics
module. In collaboration with Community Outreach and Engagement (COE), CRTEC will launch a postdoctoral
fellowship on Social Determinants of Cancer Health to address timely needs in this area.